NCIP HUB Maintenance and Hosting

o Abstract: The National Cancer Institute (NCI), a major biomedical research institute within the National Institutes of Health (NIH), coordinates the nation’s research program on cancer prevention, detection, diagnosis, treatment, rehabilitation, survivorship and control. As a result of the 1971 National Cancer Act legislation, the NCI has built a research community that includes regional and community cancer centers, physicians who are cancer specialists, cooperative groups of clinical researchers, and volunteer and community outreach groups. NCI also has initiated cancer control programs to hasten the application of knowledge gained through cancer research.